Personalized vaccine immunotherapy in combination with anti-PD 1 antibody for recurrent or metastatic squamous cell carcinoma of the head and neck

PROJECT SUMMARY/ABSTRACT
Not Requested

Public health relevance
PROJECT NARRATIVE Not Requested